IGF::OT::IGF Drug Abuse and HIV Data Archive; POP 8/1/2014 - 3/31/2018; FY14 N01DA-14-5576

The contract will promote the secondary use of social science addiction and HIV data by providing archiving services.